Urine podocyte and podocyte GL3: novel screening tools for phenotype assessment and treatment efficacy in Fabry disease

Project Summary-Abstract:
Fabry disease is caused by deficiency of a lysosomal enzyme a-galactosidase-A, that leads to accumulation of
the enzyme substrates and mostly globotriaosylceramide (GL3). Since Fabry disease pathogenesis is closely
linked to GL3 accumulation, establishing a diagnosis of Fabry disease requires demonstration of a-
galactosidase-A deficiency and accumulation of GL3 in cells/organs. Newborn screening can identify infants
with a-galactosidase-A deficiency. However, there is no non-invasive assay for detection of GL3 accumulation
in key cells. This is a challenge for deciding who needs treatment and when treatment needs to be started.
Fabry nephropathy is a major complication and the second cause of mortality in patients with Fabry disease.
Podocytes play pivotal role in kidney failure in Fabry patients. Our study will use state-of-the-art imaging flow
cytometry techniques to develop standardized protocols for quantifying podocytes in the urine as an indication
of Fabry nephropathy. In addition, our assay will measure GL3 in urine podocytes. We will develop standard
protocols using a Fabry podocyte cell line that we have developed using CRISPR/Cas9 approach. We will
calibrate our GL3 measurement technique using correlative electron microscopy and unbiased stereology. We
will test our protocols in urines collected from patients with Fabry disease with correlations with urine function
and relevant clinical data. Development of this test will be an important addition to screening Fabry patients for
early detection of disease complication and treatment.

Public health relevance
Project narrative: Fabry disease, cause by lysosomal enzyme a-galactosidase A deficiency, is a candidate condition for newborn screening; however, while newborn screening identifies infants with enzyme deficiency, does not provide insight about the risk for disease development or onset of the disease which are important parameters for treating patients. Progressive kidney injury is a major complication of Fabry disease and the second cause of mortality in the patients. Our project will develop a non-invasive screening assay that quantifies the number of podocytes lost in urine, as an indicator of Fabry kidney disease, and measures GL3 in urine podocytes, as an indicator of phenotype severity and a potential biomarker to assess treatment efficacy.